GENES CONTROLLING SOCIAL BEHAVIOR IN ANTS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. There has been no change in the support of key personnel since the last reporting period. There will not be any significant change in the level of effort for key personnel in the next budget period. The estimated unobligated balance will not be greater than 25% of the current year's budget.